Comparative Effectiveness Research & Cochrane Eyes and Vision (CEV)

PROJECT SUMMARY/ABSTRACT As in related eyes throughout problem disproportionally society adapts to the constantly evolving COVID-19 pandemic, the evidence supporting face mask wearing public and in healthcare settings is strong. Yet, regular and prolonged mask use may increase dry eye- symptoms, even in individuals without a history of dry eye. The upward air flow from the mask into the likely accelerates the evaporation of the tear film, which, when masks are worn continuously for hours the work week, may result in ocular surface irritation and/or inflammation. Dry eye is global health associated with multiple underlying diagnoses that has a considerable impact on quality of life, affects the elderly and women, and is expensive to treat. a This symptoms mask understand prevalence eye-related administrative supplement will measure the ocular surface, cular environment, and dry eye-related mong a sample of healthcare workers across the job spectrum exposed to regular and prolonged use ( Aim 1 ); elucidate the potential role of masks in exacerbating dry eye-related symptoms and coping behaviors among hospital workers who participated in Aim 1 ( Aim 2 ); and assess the of barriers and facilitators of the use of environmental and behavioral modifications to reduce dry symptoms ( Aim 3 ). o a To achieve these aims, we will utilize innovative technology to measure relative humidity in front of the eyes. We will integrate qualitative and quantitative approaches and data. We will focus on underserved population and those of lower socioeconomic positions, and purposely sample from these groups. Findings from the proposed study will drive innovative and affordable healthcare solutions, promoting self-management of dry eye. The collaborations (Grant proposed work will leverage key research findings, the theoretica l basis, resources, expertise, and supported by grant Comparative Effectiveness Research & Cochrane Eyes and Vision #: UG1 EY020522).

Public health relevance
PROJECT NARRATIVE Regular of humidity regular role barriers and prolonged mask use may increase dry eye-related symptoms, even in individuals without a history dry eye. This administrative supplement will measure the ocular surface, dry eye-related symptoms, and level in front of the eyes among a sample of healthcare workers across the job spectrum exposed to and prolonged mask use. We will use qualitative and quantitative methods to elucidate the potential of masks in exacerbating dry eye-related symptoms, to understand coping behaviors, and to assess and facilitators to environmental and behavioral modification strategies to reduce dry eye-related symptoms.